Glymphatic MR Imaging and Biomarker Discovery in Aging with HIV Infection

PROJECT SUMMARY/ABSTRACT
With the advent of effective antiretroviral therapy (ART) for human immunodeficiency virus (HIV), individuals
living with HIV are experiencing longer lifespans. However, they face an increased risk of cognitive decline and
neurological complications compared to their age-matched peers without HIV. Understanding the neurobiological
mechanisms that contribute to the variability in cognitive and functional decline in aging populations, both with
and without HIV, is essential for understanding long-term health outcomes and quality of life. Among the factors
thought to contribute to the heightened risk for cognitive impairment is dysfunction of the brain's waste clearance
system. The so-called glymphatic system (GS) is thought to clear proteins through the flow of cerebrospinal fluid
via perivascular spaces (PVS) and through the brain`s parenchyma and is augmented during sleep. For example,
protein accumulation of β-amyloid (Aβ) and tau associated plaques and neurofibrillary tangles are hallmark in
Alzheimer's disease (AD), α-synuclein (α-syn) with aggregates in form of Lewy bodies are hallmark biomarkers
in Parkinson's disease (PD). Understanding mechanisms of proteins clearance from brain tissue is critical to
developing interventions prior to onset of cognitive decline but these mechanisms remain controversial. There is
some evidence that HIV infection of the CNS contributes to abnormal aging with accumulation of tau and chronic
neuroinflammation. Also, longer HIV disease duration and older age have been linked to an increased
prevalence of α-syn and Aβ and higher risk of cognitive impairment and neurodegenerative disease. Our
preliminary MRI data show more enlarged PVS, indicative of glymphatic dysfunction, in older PLWH than
controls. There are limited means of non-invasively evaluating the brain waste clearance system in vivo in human
brains. Given the proximity between the brain and the eye, tear fluid recently emerged as a promising easily
collectible sample matrix for biomarker analysis of Aβ peptides, tau, and α-syn. We propose using innovative
diffusion MRI of free water (FW) and intra voxel incoherent motion (IVIM), as proxies of brain waste clearance,
together with α-syn, Aβ, and early tau burden quantified with tear proteomics. This high-risk R21 proposal
requests funding for dMRI FW/IVIM data acquisition, tear proteomic laboratory costs, and their analyses. Data
available from an R01 study include clinical assessments, cognitive data, and sleep biomarkers. Leveraging the
deeply phenotyped PLWH and PD participant data from the parent R01 study, we propose two Specific Aims:
1. Determine associations of PVS, FW f and flow metrics with tear α-syn, Aβ, and tau burden.
2. Determine associations among IVIM metrics, protein burden, and sleep, with cognitive outcomes in
PLWH and PD.
This proposal addresses a critical gap in understanding the role of microscopic FW diffusion and flow within the
context of α-syn, Aβ, and tau protein accumulation, disrupted sleep-wake behavior, and cognitive worsening in
people aging with HIV infection.

Public health relevance
PROJECT NARRATIVE The HIV-infected population is surviving into old age, thanks to medicine regimens that are successful in lowering deadly viral loads, such that 47% (454,684) of Americans living with HIV/AIDS are aged 50 years and older, but who are now at risk for accelerated neurocognitive decline and vulnerable to neurodegenerative disorders. As HIV infection and aging are associated with increased protein accumulation in the brain, including α-synuclein, β-amyloid, and tau –hallmarks of Parkinson's and Alzheimer's disease– this study seeks to investigate whether the brain waste clearance system is dysfunctional and contributes to cognitive decline, by utilizing novel noninvasive diffusion MRI technology of microscopic free water movement together with tear proteomic technology. It is critical to gain a better understanding of the link between brain waste clearance mechanisms and protein accumulation in relation to cognition and clinical outcomes in older people living with HIV infection and thus identify a critical roadblock to effective therapeutic development.